Goizueta Alzheimer's Disease Research Center

PROJECT SUMMARY/ABSTRACT: OVERALL
The Goizueta Alzheimer’s Disease Research Center (GADRC) at Emory University provides Georgia and the
region with comprehensive clinical, research, and educational programs. Leveraging our local environment
that promotes and supports innovative projects and a central theme of mixed etiology dementia, our studies
will enable greater precision in early identification, intervention, and ultimately, prevention of Alzheimer’s
Disease (AD) and related disorders (ADRD). The GADRC aims to 1) catalyze research for precision medicine
in AD/ADRD that contributes to the discovery and understanding of pathogenic mechanisms, risk and
resilience (including genetic, environmental, lifestyle, and social determinants), disease subtypes, and new
biomarkers and therapeutic targets; 2) promote diversity in research, with a special emphasis on AD/ADRD in
African Americans; 3) facilitate the translation of research discoveries into clinical practice, leveraging primary
care and specialty care at Emory, and statewide memory assessment clinics (Georgia Memory Net); 4)
collaborate to advance high-impact AD/ADRD research, care, and education initiatives nationally and globally;
and 5) attract and train the next generation of AD/ADRD researchers, addressing areas of need including
under-represented minorities and the shortage of new investigators, especially clinician scientists and data
scientists. Eight cores work in a concerted manner to effectively recruit, evaluate, and engage a diverse
cohort of participants in a variety of research studies. The Outreach, Recruitment and Engagement Core aims
to sustain 50% African American participation and expand disease heterogeneity in the Clinical Core cohort.
The Clinical Core provides detailed phenotyping with the Uniform Data Set 4, and numerous supplementary
measures. The new Imaging Core will provide advanced brain MRI and PET, and the new Lifestyle &
Empowerment Core will facilitate research, education, on the understanding, and translation to clinical
practice of lifestyle as a risk factor for AD/ADRD. The Biomarker Core provides state-of-the-art proteomic and
genetic data complemented by a large repository of blood, CSF, and DNA samples, and a large bank of well-
characterized postmortem brains and spinal cords is supported by the Neuropathology Core. The Data
Management and Statistics Core hosts an integrated database to facilitate analyses and sharing of data. All
GADRC resources will continue to be distributed widely, including for research Developmental Projects and to
support local and national collaborations. Generous non-federal support is used to seed a large base of
innovative research. The GADRC educational programs reach a broad audience from trainees to the public.
The Research Education Component cultivates and trains the next generation of scientists. With a strong
commitment to diversity and inclusiveness, we benefit from the engagement of a large, multidisciplinary, core
of training faculty from institutions throughout the greater Atlanta area. Collectively, the GADRC is poised to
continue to make important contributions to the national strategy for AD/ADRD treatment and prevention.

Public health relevance
PROJECT NARRATIVE: OVERALL The Goizueta ADRC (GADRC) at Emory continues to grow dramatically and is submitting this application to seek funding for the next funding cycle. The GADRC contributes to the NIH/NIA-funded network and plays a critical role in the coordinated response to the growing public health threat from Alzheimer’s disease (AD) and related disorders (ADRD). Emory’s participation in the network fosters research to understand the complex mechanisms that explain pathological and clinical heterogeneity of AD/ADRD to enable greater precision in early identification, intervention, and ultimately, prevention of disease of AD/ADRD.